PREVENTIVE VALUE OF MODERATE EXERCISE IN TWO TYPES OF HIGH RISK PREGNANCY

The purpose of this study is to begin to apply the findings of the ongoing exercise in pregnancy project to demographically high risk populations to test the hypothesis that beginning a regular exercise regimen will decrease risk and improve outcome. We will be studying two at risk populaces who are at the extremes of reproductive life: a group of young, primigravid or secundigravid, low income, urban women and a group of primigravid women over the age of 36. In both groups, the risks of pregnancy are increased.